Understanding the Relationship between Medicare Advantage Provider Network Diversity on Health Disparities

Project Summary
Black and Hispanic Medicare beneficiaries enroll at higher rates in the Medicare Advantage program but
receive lower quality of care and experience worse outcomes than their white counterparts. These disparities
vary markedly across plans, with some managing to deliver high quality care for traditionally marginalized
populations. It is not currently known what characteristics of these plans contribute to lower disparities for
Black and Hispanic enrollees. Prior work has established that Black and Hispanic patients tend to have better
outcomes across various conditions when seeing physicians and other providers of the same race/ethnicity. It
is not known to what extent MA plans' networks include minority physicians, and if the physician diversity in
plans' networks have downstream effects on enrollee health disparities. Without an understanding of whether
enrollees have access to a diverse set of providers in the Medicare Advantage program, these disparities are
likely to continue. Our long-term goal is to identify strategies to reduce health disparities for Black and Hispanic
enrollees in the Medicare Advantage program. The objective of this application is to develop novel methods to
measure the diversity of Medicare Advantage primary care provider networks, and to determine if network
diversity is an important factor in addressing health disparities. Our central hypothesis is that more diverse
primary care provider networks will deliver higher quality outcomes for Black and Hispanic enrollees. The
rationale that underlies the proposed research is that publicly available measures of network diversity may help
health plans better understand their own networks and help minority patients make enrollment decisions that
lead to improved downstream outcomes. Using a unique set of national Medicare Advantage network data
linked with self-reported provider race/ethnicity, we propose two specific aims: 1) to develop a measure of
primary care physician network diversity, and 2) to determine if access to diverse primary care physician
networks is associated with a reduction in disparities and improved outcomes for minority patients. This study
is innovative in that it will employ a novel linkage of provider network and race/ethnicity data to measure the
diversity of provider networks and is one of the first studies on what contributes to heterogeneity in disparities
across plans. Upon completion of this work, we expect our contribution to be a newly developed metric of
provider network race/ethnicity that can better inform stakeholders on the diversity of provider networks and a
better understanding of the role that diverse provider networks play on the outcomes of minority enrollees.
This contribution will be significant as over 3 million Black and Hispanic Medicare beneficiaries receive their
care from Medicare Advantage plans and we have little to no understanding of the providers they have access
to and whether this access is a driver of disparities in this population. The findings from this study will help to
lay an important groundwork in our understanding of the mechanisms of disparities in Medicare Advantage and
will build towards future studies on this topic.

Public health relevance
Project Narrative Black and Hispanic enrollees in the Medicare Advantage program face substantial disparities in their quality of care, however little is known about the plan level drivers of these disparities. This study will use unique methods to measure the diversity of Medicare provider networks and assess how these networks affect enrollee outcomes. This work is aligned with the NIMHD's mission as it will provide a valuable stepping stone in understanding the drivers of health disparities in Medicare Advantage plans.